Admin Core

PROJECT SUMMARY
An efficient administrative structure is essential to the design and implementation of the Multi-Omics Vaccine
Evaluation (MOVE) Consortium. The Administrative Core will be focused on facilitating communication,
collaboration, planning, data sharing, and scientific and fiscal oversight of the component research projects of
the MOVE Consortium. Through the Administrative Core, we will oversee all the goals of the Consortium and
ensure their successful, cost-effective, and timely completion. The Administrative Core will organize annual
MOVE Consortium meetings to facilitate data exchange, training and collaboration. The Administrative Core
will coordinate, schedule, and implement regularly scheduled internal teleconferencing meetings among MOVE
members, and will assist the PIs of the Cores and Projects in the preparation of progress reports, internal
compliance filings, and manuscripts to support the overall goals of the MOVE Consortium.
The Administrative Core will be responsible for the following Specific Aims: (1) create a supportive, efficient
leadership structure, (2) streamline scientific communication, (3) manage resource allocation and mediate
potential problems, (4) provide administrative support, (5) facilitate data dissemination, (6) promote
collaboration, and (7) monitor progress.